The role of mitochondrial deficits in tauopathy-linked autophagy defects

PROJECT SUMMARY
Alzheimer’s disease (AD) is pathologically characterized by the presence of extracellular amyloid plaques
consisting of amyloid b (Ab) and intracellular neurofibrillary tangles (NFTs) composed of hyperphosphorylated
tau (p-tau) in afflicted brains. In AD, tau pathology correlates with neuronal death and cognitive dysfunction
better than amyloid plaques. Thus, a deeper understanding of the pathogenic mechanisms of tau is needed.
Autophagy is a key cellular quality-control mechanism in neurons and pathological tau is known to be degraded
within lysosomes after being targeted by autophagy. Autophagy perturbation has been indicated in tauopathy
patient brains and cellular models, but the underlying mechanism remains largely unexplored. Mitochondrial
abnormalities are a prominent feature of tauopathy. We recently revealed that deficits in synaptic distribution of
mitochondria occur early in tauopathy preceding tau pathology, which is caused by reduced expression of
Mitochondrial Rho GTPase (Miro), a well-studied KIF5 motor receptor driving mitochondrial anterograde
transport. In a pilot study investigating whether such early mitochondrial deficits contribute to autophagy deficits
and tau buildup in cultured tauopathy neurons, we have observed that overexpression of Miro increases
autophagosome/autophagic vacuole (AV) biogenesis which leads to a significant reduction in p-tau
accumulation. Recent studies have uncovered that phosphatidylethanolamine (PE), a major component of the
AV membrane, plays a pivotal role in autophagy initiation and AV membrane elongation, and that the supply of
PE constitutes a limiting factor for autophagy activity. In mammalian cells, PE is mainly synthesized in the
endoplasmic reticulum (ER) and mitochondria. Prior work implies that pools of PE from these two distinct
biosynthetic pathways are compartmentalized and do not mix freely within cells. Importantly, we found that
tauopathy neurons exhibited mitochondrial PE biosynthesis impairment whereas overexpression of Miro led to
an increase in mitochondrial supply of PE for AV biogenesis which was abolished by inhibition of PE
biosynthesis in mitochondria but not in the ER, thus supporting a novel role of Miro in mitochondrial PE
biosynthesis essential for AV biogenesis and tau clearance in tauopathy neurons. However, detailed
mechanisms underlying this new role of Miro have yet to be identified. Based on these preliminary studies, we
hypothesized that Miro overexpression rescues autophagy deficits and alleviates tau pathology by
enhancing the PE biosynthetic pathway in mitochondria, thereby mitigating memory deficits in
tauopathy. We will determine the mechanism underlying Miro-enhanced autophagy in tauopathy neurons and
examine whether neuronal overexpression of Miro rescues autophagy deficits and ameliorates tau
pathology/cognitive deficits in tauopathy mice. The successful completion of this study will provide mechanistic
insights into a novel role of Miro in mitochondrial PE biosynthesis for autophagy-mediated tau clearance and will
likely establish Miro-enhanced autophagy as a new, potentially therapeutic strategy for combating tauopathies.

Public health relevance
PROJECT NARRATIVE (RELEVANCE) While the clinical outcomes of amyloid b (Ab)-based therapies for Alzheimer’s disease (AD) have been disappointing, pathologically phosphorylated tau and its associated neurofibrillary tangles (NFTs)-linked tau pathology clinically correlates better with dementia than amyloid plaques composed of Ab in Alzheimer’s disease. Mitochondrial deficits are an early feature of tauopathy preceding tau pathology. The proposed studies aim to provide mechanistic insights into a novel role of mitochondria in autophagy-mediated tau clearance in the context of tauopathy and to test a new, potentially therapeutical strategy for combating tauopathy diseases, including Alzheimer’s disease and frontotemporal dementia (FTD).